Multidisciplinary studies on overcoming SARS-CoV-2 main protease drug resistance and on fitness costs

ABSTRACT
The Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) has caused a global pandemic since first
emerging in 2019. Since, Pfizer, Inc. (USA) developed Paxlovid™, an FDA-approved antiviral containing the protease
inhibitor nirmatrelvir (NIR) that has seen moderate success in treating SARS-CoV-2 infections. The main protease
(Mpro) of SARS-CoV-2 cleaves the viral polyproteins to release proteins essential for replication. NIR mimics the Mpro
consensus sequence, thus covalently blocking Mpro activity and viral replication. However, resistance mutations to
NIR have started to develop as its use increases globally. Understanding how such substitutions confer
resistance and balance the impacts on fitness will enable the strategic design of the next generation of Mpro
inhibitors. My preliminary data and published experiments have identified drug resistance mutations (DRMs) in Mpro
that confer significant resistance to NIR including E166V. Further, I have demonstrated that the E166V substitution
remains susceptible to GC376, a feline coronavirus protease inhibitor, and PF-00835231, developed during the
SARS-CoV-1 epidemic. E166V also severely decreases viral fitness and requires compensatory mutations such as
L50F to rescue fitness. Despite this fitness cost, E166V and L50F/E166V were both observed in patients treated with
Paxlovid™ during the clinical trial, and recent case studies also identified the L50V/E166V combination. It is unclear
how E166V decreases fitness and why mutations at Leu50 restore fitness. Structural work from other labs and my
preliminary data indicate Mpro forms an active homodimer with the N-terminus from the opposite protomer interacting
with Glu166. Loss of these interactions due to the E166V mutation are likely to disrupt Mpro dimerization and,
consequently, activity. Of note, dimerization has not been studied in the context of drug resistance, and the role of
Leu50 mutations in restoring fitness is poorly understood. Building upon my previous work, I will analyze E166V and
L50V/E166V using virological, biophysical, and structural techniques. The goal of my project is to characterize
mechanisms of NIR resistance, determine how DRMs impact Mpro activity and fitness, and investigate
strategies for overcoming NIR resistance. I hypothesize that DRMs alter the intermolecular interactions in the
active site resulting in decreased binding of inhibitors and Mpro dimer formation. Aim 1 will characterize the effect of
the selected substitutions on Mpro resistance to NIR, GC376, PF-00835231, and a novel inhibitor shown to inhibit
E166V Mpro (NIP-22c) using a virus-like particle (VLP) assay (Aim 1.1) and elucidate the mechanism of and strategies
for overcoming NIR resistance using biochemical (Aim 1.2) and crystallographic studies (Aim 1.3). Aim 2 will
investigate the effect of E166V and L50V on viral replication efficiency in cells (Aim 2.1) and on Mpro dimerization in
vitro using biochemical methods (Aim 2.2). This project will provide valuable insights into mechanisms of drug
resistance, impacts on viral fitness, and strategies for overcoming NIR-resistant SARS-CoV-2 Mpro informing the
design of next-generation antivirals targeting Mpro and future development of pan-coronavirus antivirals. Completing
this project will train me in techniques and skills essential for my future career as an independent scientist.

Public health relevance
PROJECT NARRATIVE Severe Acute Respiratory Syndrome Coronavirus-2 (SARS-CoV-2) has caused a worldwide pandemic, and further development of effective antivirals is required to supplement vaccination efforts. This project will characterize how substitutions in the SARS-CoV-2 main protease (Mpro) reported in clinical samples confer resistance to nirmatrelvir (NIR), how other antivirals circumvent these substitutions to inhibit NIR-resistant Mpro, and the fitness cost associated with these substitutions. Understanding how multiple antivirals inhibit NIR- resistant Mpro will provide strategies for designing the next generation of protease inhibitors to treat coronavirus disease 2019 (COVID-19) and help protect us against future coronavirus pandemics.